Placental NAD and its effect on labor onset

PROJECT SUMMARY
Preterm birth is the leading cause of death in children through age 5 worldwide, and our lack of
effective therapies for preterm labor reflects major gaps in our understanding of the mechanisms regulating
labor onset, both at term and preterm. While a tremendous body of work recognizes fundamental roles of
NAD+ in diverse organ systems, extension of such studies to the placenta is an obvious gap. Having previously
demonstrated that loss of metabolic homeostasis in the placenta promotes labor onset, this project will test the
hypothesis that NAD+ is a key effector of placental metabolism whose dysregulation is coupled with labor
onset. Aim 1 is designed to define the disposition of NAD+ and its precursors across the maternal-fetal
interface, via real-time flux experiments using radioisotope-labeled precursors in primary trophoblasts and in
pregnant mice in vivo. These experiments will additionally make use of a mouse model with targeted placental
deletion of Nampt, a key enzyme in the NAD+ salvage pathway. Aim 2 is designed to elucidate mechanisms by
which nicotinamide supplementation may delay labor onset in mice, by interrogating putative pathways in
cellular and in vivo models. Bringing together an innovative multidisciplinary mentorship team, this project will
achieve mechanistic interrogation of placental metabolism and molecular biology using an array of model
systems.
Moreover, this project will provide a robust career development platform for the candidate, spanning: 1.
mastery of techniques for isotope-labeled flux experiments, 2. didactic education in placental biology as well as
mass spectrometry and related computational methods, 3. access to professional activities including grant-
writing and leadership workshops, and 4. graduated exposure to responsibilities such as mentoring young
trainees and reviewing manuscripts for journals in the field. Career guidance will be provided by an Advisory
Committee in addition to the mentor/co-mentor/collaborator team. In the setting of exceptional institutional
commitment and a training plan optimized for a targeted new skill set, this project will comprehensively provide
a rich scientific platform for launching the candidate’s independent career further investigating placental
metabolism and adverse outcomes in pregnancy.

Public health relevance
PROJECT NARRATIVE Preterm birth is the leading cause of death in children through age 5 worldwide, and our lack of effective therapies for preterm labor reflects major gaps in our understanding of the mechanisms regulating labor onset, both at term and preterm. This project will test the hypothesis that dysregulation of key effectors of placental metabolism is coupled with labor onset. By characterizing the flux of these metabolites across the maternal- fetal interface, and in elucidating mechanisms by which their dysregulation triggers labor onset in mice, this project will offer insight into the therapeutic potential for supplementation of specific metabolites in preventing preterm labor.